Utilizing gene-level biomarkers of AD to identify pathophysiological mechanisms in human neurons

Abstract Summary
Recent advances AD therapeutics increases the urgency to identify individuals at risk for developing
Alzheimer’s disease (AD). This effort can likely be accelerated using stem cell biology approaches which have
led to the ability to generate human induced neurons (HiN) directly from easily obtainable patient cells such as
fibroblasts. This serves as a powerful tool for studying aging and disease-related processes in clinically
relevant cell types. Meta-analysis studies of existing transcriptomic databanks from AD patients and healthy
individuals without dementia (nonAD) have also provided new insight into underlying pathophysiological drivers
contributing to a diagnosis of AD. While these gene expression profiles have been identified for AD risk which
carryover from the individual to their directly transformed neurons (human induced neuron, HiN). This is a
crucial missing link needed to capture the physiological outcomes of these gene network profiles in order to
identify associated mechanisms of metabolic stress, pathological protein aggregation and synaptic
pathophysiology – all key features of AD. Therefore, we will apply neurophysiological and cellular functional
analyses to HiNs derived from representative individuals diagnosed with sporadic or familial AD, as well as
age/sex-matched nonAD controls, to identify functional consequences of these genomic variations in the
human population.
Our overall objective is to identify gene-pathway based biomarkers or risk factors for AD and define the
neuronal pathophysiological phenotypes associated with these gene pathways. We will test the hypothesis
that synaptic signaling, metabolism and protein handling processes in neurons derived from the AD population
will reflect the alterations in gene pathways that distinguish healthy aging processes from AD pathogenesis,
and thus can serve as important biomarkers. In Aim 1 we will identify mitochondrial functional deficits
associated with alterations in glucose metabolism gene pathways in AD. In Aim 2 we will identify pathological
manifestations of altered gene pathways regulating autophagy and protein mishandling in AD patients. In Aim
3 we will identify neurophysiological and synaptic signaling effects corresponding with altered gene networks in
AD that underlie cognitive decline. The combination of our expertise in induced neuron production as well as
bioinformatics and neurophysiology assays makes this a powerful and innovative proposal that will provide
important insights into risk factors and biomarkers of AD. This comes at a crucial time in the AD field where it
is imperative to identify at risk individuals early in order to maximize benefits of new therapeutics becoming
available.

Public health relevance
Narrative: Our overall objective of this study is to identify key transcriptomic-based biomarkers and risk factors in AD and determine the pathophysiological consequences of these differentially expressed gene pathways that contribute to cognitive loss. Using bioinformatic analyses of existing datasets, the lab of Dr. Potashkin has identified several key gene pathways in AD that associate with testable neuronal signaling cascades. By identifying the functional deficits associated with these pathways in human neurons derived from AD and nonAD individuals, these gene-based biomarkers can identify at risk individuals who may benefit from newly developed AD therapeutics.